GODDESS (Gathering Online for Dialogue and Discussion to Enhance Social Support): Engaging young African American women in a virtual group app to address alcohol misuse, sexual risk, and PrEP in NC

PROJECT SUMMARY/ABSTRACT
The intersection between alcohol and other drug (AOD) use among young African American women at
risk for HIV is a public health issue. Recent epidemiological data highlight increases in alcohol misuse
among young African American women, especially since COVID-19. These issues are coupled with
persistent disparities in HIV and other sexually transmitted infections (STIs) for young African American
women. Eliminating persistent disparities in HIV acquisition is key to ending the HIV epidemic, particularly in
the U.S. South. Consequently, there is a critical need to decrease alcohol use and impaired sex and to
increase pre-exposure prophylaxis (PrEP) uptake as prevention for this key population.
The proposed study builds on decades of research of a best-evidence woman-focused intervention,
including collaboration with health departments to address AOD use, sexual risk, and violence prevention.
Most recently, the study team found the delivery of the intervention via mobile health (mHealth) had findings
comparable with face-to-face delivery, with reduced odds of heavy alcohol use and impaired sex, suggesting
that scalability via mHealth is a viable option. The next logical step is to add and test a virtual group
component, as recent participant feedback across several studies with African American women in North
Carolina has shown additional group engagement and support is highly desired. Consequently, in response
to RFA-AA-21-016: HIV Prevention and Alcohol, this application addresses the following specific aims:
Aim 1. To modify an evidence-based mHealth AOD use and sexual risk reduction intervention to
include a virtual group component and information about PrEP for utilization. Initial research activities
include focus group discussions with 24 African American young women who misuse alcohol and 16 service
providers, as well as pretesting of the virtual group component. This brief iterative process will include
modifications and refinements based on content (PrEP) and technology (from tablet to smartphone) and will
include review from our Community Collaborative Board.
Aim 2. To test the modified mHealth intervention (with the group component) relative to the mHealth
intervention in a two-arm randomized trial with young African American women (aged 18 to 30) who
misuse alcohol. A total of 500 participants who are HIV-negative who engage in heavy alcohol use will be
enrolled across two North Carolina counties and referred to their local health departments for PrEP. Primary
biobehavioral outcomes assessed will include reduced alcohol use (self-reported and biological, including
PEth), increased PrEP uptake (self-reported and biological), and reduced sexual risk (self-reported
condomless sex and impaired sex and biological testing for HIV/STIs) at 3-, 6-, 9-, and 12-month follow-ups.
Aim 3. To assess acceptability, adoption, and cost of the virtual group component as a strategy to
increase engagement with the mHealth intervention and PrEP utilization. Acceptability will be assessed
via satisfaction surveys and post-study interviews, adoption via data analytics measuring engagement in the
group and examined as a meditator of intervention outcomes, and cost via data collected about time and
resources of implementing the group component.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it seeks to prevent HIV among young African American women in the U.S. South—a population that continues to experience a disproportionate burden of the epidemic. The proposed research aims to test a virtual peer support group accessible via smartphones, with the goal of reducing alcohol misuse and sexual risk and increasing pre-exposure prophylaxis use.